EFFECTS OF ETHANOL ON CARDIOVASCULAR FUNCTION

The purpose of this study is to determine the acute suppressive effects of ethanol on cardiovascular functioning. This is the research project of the first year medical student class.